USC-Yale Roybal Center for Behavioral Interventions in Aging

Abstract
The Behavioral Intervention Development Core will develop innovative and scalable behavioral interventions to
improve healthcare delivery for aging adults. The Core will focus on systematic testing of mechanisms of
behavior change that drive intervention effectiveness. Following the NIH Stage Model for Behavioral
Interventions, the Core will carry out a series of 10 clinical trials. To ensure impactful research, the program
has established a network of six diverse health systems that support research on value-based care. The
External Advisory Committee, comprised of executives from these systems, along with scientific and
methodological experts, plays an integral role in informing the Center's funding priorities and ensuring the
translation of behavioral mechanisms into real-world applications. In the first year, two randomized trials will be
conducted to address barriers to the adoption of value-based practices and explore associated mechanisms of
behavior change. The first study involves adapting a multifaceted medication safety intervention that showed
mixed results in a Stage IV replication of a successful Stage III trial. This intervention will be modified to
incorporate recent findings from behavioral science and will test whether the identity of the messenger
moderates the effect of behavior change. The second trial aims to promote patient uptake of a healthcare
proxy and examines the mediating role of planning prompts. The specific aims of the trials are as follows: Aim
1 will establish an infrastructure for developing and testing potent, scalable interventions that advance scientific
mechanisms of behavior change and employ the NIH Stage Model. This includes maintaining and extending
our network of implementation partners, updating requests for applications and scoring based on scientific
evidence and implementation priorities, and providing support to awardees throughout the research and
intervention development process. Aim 2 will adapt and test a multifaceted medication safety intervention in a
Stage III cluster randomized trial, comparing the effectiveness of different forms of scalable feedback on the
overuse of potentially inappropriate medications. Hypotheses will explore the reduction of medication
prescribing through automated feedback messages based on aspirational social norms and the moderating
effect of different types of messengers. Aim 3 will conduct a Stage III randomized trial to assess the efficacy of
encouraging patients, prior to primary care provider appointments, to complete the health care proxy portion of
an advanced directive, with or without a planning prompt. Hypotheses will examine the impact of an
easy-to-use health care proxy form and the additional effect of a planning prompt on increasing health care
proxy designation. The Core's ultimate goal is to advance the behavioral science of value-based care and
improve the health and well-being of aging populations.

Public health relevance
PER RFA, NO NARRATIVE NEEDED FOR COMPONENT ON MULTI PROJECT SUBMISSION.